Enabling Dexterous Intraocular Surgery with Robotic Assistance

Project Summary / Abstract
The goal of this grant is to develop enabling technology to address fundamental limitations in robotic
intraocular microsurgery with a specific focus on high-dexterity micromanipulation. Vitreoretinal surgery may be
the most technically demanding type of eye surgery and deals with the surgical treatment of retinal and posterior
segment diseases. Following the trend in microsurgery, robotic assistance, enhanced by advanced imaging, has
the potential to fundamentally change the field of intraocular surgery. Still in its early stages, robotic retinal
surgery has been cautiously introduced into the operating room and has been successfully evaluated in a limited
number of clinical trials. Owing to its demonstrated capabilities, robotic intraocular microsurgery has the potential
to assist the surgeon and provide super-human physical capabilities, enabling unprecedented as well as safer
surgical care for patients. Among the most relevant procedural tasks that may benefit from the use of robotic
assistance is epiretinal membrane (ERM) peeling, the most common vitreoretinal surgery performed in the US.
The incidence of intra and postoperative complications ranges from 2% to 30%, depending on the circumstances.
The main complication is varying degrees of mechanical retinal trauma that result from accessing the membrane
edge or due to excess forces applied during membrane removal. Current limitations and challenges of robotic
approaches include logistically cumbersome setup, limited access to important portions of the retina, and lack of
force feedback to the surgeon at the tool tip and shaft. Similar problems exist in laparoscopic surgery. To date,
non-ocular robotic systems have demonstrated significant dexterity enhancement by integrating additional
degrees of freedom and force-sensing capabilities at the distal end of the surgical instruments.
To prove the hypothesis that a high-dexterity robotic assistant will overcome important limitations in
conventional ophthalmic microsurgical procedures, we propose the following specific aims: (1) Clinically
compatible high-dexterity robotic system: develop a miniature robotic forceps with snake-like distal end, and
embed optical fibers-based sensors on the tool shaft, allowing force-sensing at both the tool tip and sclerotomy,
and integrate the dexterous manipulator with the Steady Hand Eye Robot (SHER); (2) Control methods for high-
dexterity robotic system: develop teleoperated control for the dexterous manipulator and SHER, combine
teleoperated and cooperative control for the integrated system, and develop control schemes able to assist the
surgeon with sensorimotor guidance for safe robotic ERM peeling; (3) Validate the high-dexterity robotic system
for ERM peeling: validate the capabilities of the proposed system for ERM peeling with established ex-vivo
phantoms (membrane of fertilized chicken eggs) and in-vivo biological membranes (pig eyes). This highly
innovative system will fuse tool-tissue force information with intraoperative guidance via a high-dexterity robotic
assistant surgical platform with cooperative and teleoperated control.

Public health relevance
Project Narrative Removing membranes from the surface of the retina is among the most common vitreoretinal surgeries performed in the US. This delicate procedure can have a high incidence of intraoperative complications, that could benefit from the use of robotic assistance. Current limitations and challenges of robotic approaches include cumbersome setup, limited access to important portions of the retina, and lack of force feedback to the surgeon. To consistently enable human utilization of robotics in epiretinal membrane peeling, we propose to develop a novel system that will fuse tool-tissue force information with intraoperative guidance via a high-dexterity robotic assistant surgical platform with cooperative and teleoperated control.